Building a Respectful, Inclusive Culture

ABSTRACT
A diverse U.S. biomedical research workforce is essential for developing innovation in basic, clinical,
translational research and healthcare and is necessary for improving the nation’s health. The proposed
University of California (UC) San Diego Building a Respectful, Inclusive Culture (BRIC) Program will develop
training modules that will catalyze changes in scientific, clinical, and research training environments optimal for
productive learning and research - free from harassment, intimidation, and discrimination - where everyone
feels safe and treated in a respectful and supportive manner. The outcomes of a pilot study of the proposed
training modules, conducted for a small group of faculty, are highly encouraging. The overarching goal of the
UC San Diego BRIC Program is to create a culture of respect, psychological safety and inclusion and support
in the academic environment allowing trainees and learners to work and learn in an environment conducive to
the pursuit of excellence, free of harassment and discrimination. The specific objectives are: 1) to recruit
Health Sciences faculty participants with an emphasis on faculty mentors and researchers that participate in
UC San Diego NIH-supported T32 training programs, including four large NIGMS-supported T32 programs and
other training programs that focus on individuals underrepresented in the biomedical workforce, such as
including the Initiative for Maximizing Student Development (IMSD) and Institutional Research and Career
Development Award (IRACDA), 2) to train Health Sciences faculty participants using an evidence-based
curriculum tested in our pilot BRIC program to enhance a culture of respect, psychological safety and inclusion
and support, 3) to evaluate the effectiveness of the BRIC program on training environments using a
randomized case/control study design, and 4) to assess the impact of the BRIC program on the Health
Sciences climate. We will integrate instruments measuring psychological safety and inclusion into our
published Health Sciences Faculty Climate Survey and resurvey our faculty at the end of the proposed study.
The UC San Diego BRIC Program is directed by two PIs with a history of mentoring and training. They have
been successful in designing and implementing career development and mentoring programs specifically for
women and individuals from underrepresented racial/ethnic backgrounds. The PIs are both women and one is
from an underrepresented background and have led numerous successful faculty career development
programs and well-respected track record of leading extramurally-funded training programs. The BRIC
Program will be administered centrally through the UC San Diego Health Sciences Office of Faculty Affairs.
The BRIC training modules will be made available to the scientific and educational community, as well as to
the general public.

Public health relevance
NARRATIVE The development of a highly skilled diverse workforce that will impact all aspects of health related research efforts is essential to sustain the Nation’s research priorities, scientific and economic competitiveness. The UC San Diego Building a Respectful, Inclusive Culture Program will address this need by providing training modules that will catalyze changes in scientific, clinical and research training environments optimized for productive learning and research that are free from harassment, intimidation and discrimination. Creating a culture of respect, trust and safety in the academic environment is imperative for protecting trainees and learners, allowing them to learn and work in an environment conducive to the pursuit of excellence.